NARCH 11- Student Development Program

Program Summary-Overall
Indian Health Council, Inc. (IHC) with San Diego State University (SDSU) and University of California San
Diego (UCSD), intends to build upon their already existing long-term research partnership in the proposed
projects/studies in the NARCH X application.
The Student Development Program will further expand and refine strategies to recruit students from local
academic institutions into biomedical and behavioral sciences as well as, continue to provide strong mentorship
and guidance for the students in and outside of the region. American Indian and Alaska Native (AI/AN) students
are the least likely of any minoritized group to complete a bachelor’s degree and bachelors, masters, and
doctoral degree attainment has remained the same or decreased since 2000 in both STEM and non-STEM
fields. This is despite AI/AN communities facing some of the largest disparities in health outcomes, thus justifying
a critical need to train more AI/AN health scientists to improve health equity. The CA-NARCH SDP was
established in 2003 and is a partnership between Indian Health Council (IHC), serving 9 regional tribes, and the
academic partners of San Diego State University (SDSU), University of California San Diego (UCSD), California
Sate University- San Marcos (CSUSM), and Palomar Community College (PCC). The CA-NARCH SDP has
significantly addressed gaps in AI/AN academic achievement and has supported 135 students, with 97% being
retained in their STEM programs over its 17 year history. Thus far, 10 students have received a PhD, with 18
additional students currently in PhD programs. 28 students have completed masters degrees, and 15 are currently
in masters programs. Students are dedicated to working in Indian County and 17 students currently have full time
positions in Indian Country; Two students have thus far become faculty members at 4 year universities. The aims
of the CA-NARCH SDP include: 1) Identify and recruit AI/AN students in the biomedical and behavioral sciences
from community college through graduate school into the CA-NARCH SDP program; 2) Retain AI/AN students
in their respective higher education programs and develop and enhance their knowledge, skills, science-self
efficacy, and persistence to succeed in STEM programs to successfully matriculate into graduate programs; 3)
Engage and provide training for AI/AN students in biomedical and health research to increase their
competitiveness for jobs/graduate school and their likelihood of becoming health/science researchers; 4) Increase
the cultural interface and competencies of the CA-NARCH students and encourage AI/AN community
engagement and trust in research. Centered at IHC, the CA-NARCH SDP has established infrastructure with a
SDP team, including a full-time native coordinator (Luiseño), and an established presence and leads on the 4
surrounding campuses. Students are recruited from the 4 campuses, AI/AN organizations, faculty directors of NIH
and NSD funded science enrichment programs, and from local tribes. Retention methods are multiple and include
engaging students in research through existing NIH and NSF funded program, the CA-NARCH Directed Research
(CANDR) program with campus and community based research, and in summer and yearlong research programs.
Students receive continual mentorship from the CA NARCH SDP team, develop individual development plans,
and will be assigned a cultural mentor who will provide additional guidance to students. Students will all
participate in workshops and seminars that will enhance their science skills, provide training in indigenous
research methods and that will expose students to established AI/AN researchers working in AI/AN communities.
Cultural interface and community trust in research is enhanced by CA-NARCH SDP team and student
presentations at community events and through cultural days. Evaluation of the program includes quantitative and
qualitative measures and serves to assess program success and enhancement.
Lastly, the Administrative Core will function as administrative support for the student project and individual
research studies by providing training through the Tribal IRB, providing/dispersing information on resources and
mentoring opportunities, and guidance in evaluation planning.

Public health relevance
Program Narrative Indian Health Council, Inc. (IHC) with San Diego State University (SDSU) and University of California San Diego (UCSD), intends to build upon their already existing long-term research partnership with the following proposed projects/studies in the NARCH X application: Student Development Program and the Administrative Core. These projects will further expand and refine strategies to recruit students from local academic institutions into biomedical and behavioral sciences as well as, continue to provide strong mentorship and guidance for the students in and outside of the region and by providing administrative and fiscal oversight, coordinating communication and dissemination of information to foster the academic and community partnerships, supporting the CA-NARCH SDP in establishing a trained cohort of AI/AN scientists dedicated to impacting the health disparities of AI/AN populations, and by guidance in and conducting relevant evaluation to ensure the success of the core and CA-NARCH SDP.